Examining Potential Mobile Measures of Strain, or the Accumulated Effects of Exposure to Demands

PROJECT SUMMARY/ABSTRACT
The proposed K01 application will strongly support Dr. Raymond Hernandez's long-term career goal of
developing tools usable in interventions to promote efficient and effective recovery from strain. In the recovery
from work literature, strain refers to effects (e.g., on affect, physiology, fatigue levels, etc.) of exposure to
stressors or any other demands. The symptoms of strain can be alleviated with sufficient engagement in
recovery activities. If strain is allowed to accumulate however, it can lead to negative outcomes such as
increased likelihood and absenteeism and lower job performance. Strain is frequently allowed to accrue
because its symptoms are often unobservable and there are no established objective strain measures, making
strain easier to ignore. In the US, insufficient recovery from work-related stress and associated strain has been
estimated to cost $125 billion annually from productivity losses and healthcare spending.
The proposed K01 study aims to perform secondary data analysis on several existing datasets to investigate
whether digital health technology tools that measure physiological functions such as heart rate variability
(HRV) and performance-based measures such as mobile cognitive testing can serve as objective indicators of
strain. This application is in response to the National Institute of Occupational Safety and Health (NIOSH)
strategic goal to “promote safe and healthy work design and well-being”, particularly its intermediate goals
focused on “Total Worker Health”. It is also in response to the Healthy Work Design and Well-Being cross-
sector objective of promoting a sustainable work-nonwork interface.
Mentored research towards completion of study aims will be supplemented with structured career development
activities. These activities will fill critical gaps in Dr. Hernandez's past training by enabling him to achieve the
following career goals: developing knowledge of passively collected physiological data, learning nuances of
ambulatory cognitive assessment, obtaining knowledge of factors influencing use of mobile health technologies
(e.g., how to promote uptake of mobile technologies by healthcare systems), and professional development for
career scientists (e.g., grant writing). I will be supported by a highly qualified mentorship team, and by the
outstanding training environment provided to young researchers by the University of Southern California.
A desired end outcome is for mobile measures of cognitive performance and HRV to augment existing worker
recovery interventions as objective measures of strain levels, usable by occupational health practitioners (e.g.,
to monitor and document progress in recovery interventions), employers, and employees. An expected
intermediate outcome is an R01 proposal for more rigorous validity/usability tests of mobile strain indicators.
Expected outputs after completion of this proposal include multiple publications that illuminate the types of
HRV/cognition measures with associations with strain, and Dr. Hernandez's attainment of the expertise
necessary to develop novel ways of utilizing digital health technologies to help reduce workers' strain levels.

Public health relevance
PROJECT NARRATIVE In the recovery from work literature, strain refers to effects (e.g., on affect, physiology, fatigue levels, etc.) of exposure to stressors or any other demands which, if allowed to accumulate, can lead to impaired health and performance. The goals of this study are to use digital health data to see if physiological measures, such as heart rate variability, and performance-based measures, such as mobile cognitive testing, can serve as indicators of accrued strain, which is often unobservable and hence easy to ignore. The ability to utilize real- world digital health data for the identification of strain will enable enhancement of existing, and creation of new, worker recovery interventions, which could prevent the negative effects of strain accumulation.